Investigating the neural mechanisms of social memory in the hippocampal-cortical network

PROJECT ABSTRACT
Sociality is a fundamental part of our rich life as social animals. Notably, abnormalities in social cognition
are a hallmark of various psychiatric disorders such as schizophrenia and autism. Understanding the social
brain, the neural basis of social behavior, is an essential step toward addressing these issues. One of the
building blocks of social cognition is social memory, which comprises familiarity, the sense that an individual was
previously encountered, and recollection, the detailed storage and recall of social episodes. However, these two
processes have conflicting computational requirements: while familiarity requires abstraction and generalization,
recollection involves the creation of specialized representations to efficiently memorize many complex, multi-
sensory experiences. The question of how the brain implements these two processes to achieve social memory
is still open. One hypothesis is that these two processes are simultaneously implemented, and used in synergy
to optimize memory, by the hippocampal-cortical network. Here, I will test this hypothesis using artificial neural
networks and neural recordings from mice and human subjects exposed to social stimuli.
In the first aim, I will analyze data from the entorhinal cortex (EC), the main input region to the hippocampus,
of mice interacting with familiar and novel conspecifics and compare it to previous hippocampal data to reveal the
specific roles of these regions during social cognition. In the second aim, I will develop a modular computational
model inspired by the connectivity structure of the hippocampus with the EC and the neocortex, and use it to test
how specialization and abstraction can be used in synergy to achieve efficient memory. This model will be trained
to reproduce the mouse data and used to make testable predictions on how social representations in hippocampal
and cortical regions change during learning. Finally, in the third aim, I will extend the analysis to human cognition
by first analyzing previous single-cell recordings of human patients exposed to familiar and novel faces. I will
then co-design a new experiment to reveal the coordinated change of the neural code in simultaneously-recorded
hippocampal and cortical regions and directly test how the synergy between abstraction and specialization can
improve memory.
Given my quantitative training and extensive experience in collaborating with experimentalists, I am in a unique
position to conduct this work at the interface between computational modeling and cross-species data analysis.
The K99 phase of this work will take place at the Zuckerman Institute at Columbia University, a vibrant and immer-
sive scientific hub hosting world-class theoreticians and experimental neuroscientists. Thanks to the mentorship
of Drs. Fusi, Siegelbaum, and Rutishauser, all of whom are leaders in their fields, this project will allow me to
complete my training and start an independent group in interdisciplinary computational neuroscience.

Public health relevance
PROJECT NARRATIVE Understanding the social brain, the neural basis of our ability to interact socially, is a fundamental step toward addressing cognitive disorders that have been linked to disruptions in social cognition, such as autism and schizophrenia. Familiarity, the ability to tell if we know someone, and recollection, the detailed recall of past social episodes, are two fundamental building blocks of social cognition; however, it is still unknown how the brain implements these processes, which have different and conflicting computational requirements. Here, I will use recordings from animal subjects, human patients, and machine-learning models to shed light on how the memory system in the brain implements familiarity and recollection, and how these processes are combined to achieve social memory.